Donor Red Blood Cell Survival in Recipients with Sickle Cell Disease

Project Summary
Red blood cell (RBC) transfusion is an essential part of the management of sickle cell disease (SCD). The
effectiveness of transfusion therapy to treat acute disease complications and prevent chronic disease
progression have unique considerations in SCD that are dependent upon post-transfusion RBC survival. For
many individuals with SCD who receive acute or chronic transfusions, transfusion survival and thus
effectiveness is suboptimal. The NHLBI State of the Science in Transfusion Medicine symposium identified
optimization of RBC transfusion outcomes for recipients with SCD as a key clinical and research priority. The
proposed research will evaluate the impact of donor and recipient factors on the survival of transfused RBCs in
recipients with SCD and will examine mechanisms contributing to RBC clearance in both the recipient and the
donor. Based on our preliminary data, we hypothesize that RBC components from donors with G6PD
deficiency or with alpha-thalassemia trait will have decreased post-transfusion in vivo survival as compared to
normal donor RBCs. We have previously demonstrated that recipients with SCD have a much higher likelihood
of receiving transfusion from donors with these RBC conditions that are common among healthy donors with
African ancestry. We additionally hypothesize that recipients with past RBC alloimmunization responses will
have faster clearance of transfused RBCs via mechanisms of spleen and hepatic phagocytic activity. We
propose an experimental, interventional, controlled trial with a paired study design that will allow recipient and
donor factors to be assessed independently without confounding. Through large-scale next generation
sequencing (NGS) genetic screening of at least 10,000 African American blood donors through LifeSouth
Community Blood Centers, we will create a database of eligible blood donors including blood type, RBC minor
antigen genotype for matching to recipients, G6PD, and alpha-thalassemia hemoglobinopathy status. Pairs of
minor antigen-similar blood donors (G6PD deficiency to normal, and alpha-thalassemia to normal) will be
recruited for donation, with transfusion directed to pairs of recipients with SCD (alloimmunized vs. non-
alloimmunized). Biotin-labeling will be used to measure post-transfusion RBC survival kinetics. Our aims are to
(1) determine differences in post-transfusion survival for RBC components from donors with and without G6PD
deficiency or alpha-thalassemia trait, and (2) to determine differences in the clearance of transfused RBCs in
recipients with SCD with and without past alloimmunization. We will conduct the project through the Georgia
Comprehensive Sickle Cell Center at Emory University-affiliated Grady Memorial Hospital. Our project has the
potential to improve the management of RBC transfusion therapy, with focus on tangible areas such as donor
screening and selection, and identification of recipients at increased risk of suboptimal transfusion survival and
efficacy.

Public health relevance
Project Narrative The effectiveness of red blood cell transfusion therapy to treat and prevent complications of sickle cell disease has considerable variability in both clinical and hematologic responses. Understanding recipient and donor factors that impact the survival of red blood cell transfusions in individuals with sickle cell disease will increase knowledge about the mechanisms of RBC clearance and transfusion survival. This new information ultimately will help us to 1) identify reasons that patients may have poor responses to therapy and 2) modify donor aspects of transfusion therapy to improve treatment responses and decrease disease-related morbidity.